The role of H3K36 methyltransferases on non-CpG methylation patterning in the mammalian brain

Project Summary:
Human genetic studies have linked autism and related neurodevelopmental disorders (NDD) to disruption of
genes encoding epigenetic factors. While mutations in these genes can affect more than one pathway that leads
to ASD, identification of a common molecular pathway across genetic causes of ASD can provide insight into
broadly applicable therapies. Recent evidence from our laboratory suggests that a neuronal-specific form of DNA
methylation is a shared epigenetic modification that is disrupted in ASD-associated neurodevelopmental disease.
Though DNA methylation is classically considered to only occur in mammalian cells in the CpG context,
neurons are uniquely enriched for methylation in non-CpG contexts established by DNMT3A. This non-CpG
methylation primarily occurs at CA dinucleotides (mCA) and is critical for proper neuronal development and
function. Though mCA plays an important role in regulating neuronal gene expression, it is not known how the
mCA landscape is faithfully established across the neuronal genome, and whether additional NDDs involve
disruption of mCA. Recent studies outside the nervous system have suggested that histone modifications may
play a central role in directing DNMT3A-mediated DNA methylation across the genome, but it is not known to
how these histone modifications influence DNMT3A and mCA throughout the neuronal genome.
Intriguingly, mutations in H3K36 histone methyltransferases have been recently identified in ASD gene
studies. Additionally, recent studies conducted outside the nervous system have suggested that H3K36
methylation recruits DNMT3A and regulates its activity. In this proposal, I will determine how disruption of H3K36
methylation-mediated interactions with DNMT3A disturbs critical patterns of mCA across the neuronal genome
to drive brain dysfunction. In Aim 1, I will disrupt NDD-relevant H3K36 methyltransferases and measure how
DNMT3A recruitment and mCA are affected. This will define the mechanisms underlying histone and DNA
modification dynamics on regulating neuronal transcription and building our basic understanding of how
disruption of mCA drives disease. In Aim 2, I will explore how loss of H3K36 dimethylase NSD1 causes
dysregulation of neuronal genes via shared neuronal chromatin pathology observed across heterogenous clinical
syndromes of ASD. I will use genomic approaches to examine how altered DNA methylation as a result of NSD1
loss affects enhancer activity to drive transcriptional dysregulation in nervous system dysfunction and disease.
This analysis will begin to identify key downstream chromatin associated factors across a common molecular
pathway involved in multiple genetic causes of ASD to provide insight into functional cellular outcomes and
broadly applicable therapies.

Public health relevance
Project Narrative: DNA methylation is a critical epigenetic modification that is required for proper neuronal development, and improper DNA methylation is associated with autism-associated neurodevelopmental disease; but it is fundamentally unknown how the DNA methylation landscape is faithfully established across the neuronal genome. The proposed research will utilize genomic approaches to examine how the histone modification H3K36me2 functions to guide DNA methyltransferase 3A (DNMT3A) to establish the neuronal DNA methylation landscape and investigate how disruption of H3K36 methylation-mediated interactions with DNMT3A disturbs critical patterns of DNA methylation to disrupt neuronal transcription and brain function. Completing these goals will elucidate novel paradigms of H3K36 methylation function in the developing brain and provide insight into how mutations in H3K36 methyltransferases may lead to neurodevelopmental disorders.